UJMT LAUNCH: Training the next generation of leaders in global health research

ABSTRACT
Since its inception in 2012, the UJMT Fogarty Global Health Fellows Program—led by the University of North
Carolina at Chapel Hill, Johns Hopkins University, Morehouse School of Medicine, and Tulane University—has
provided a critical pathway to global health research careers. Our 252 trainees have collectively secured $88.5
million in grant funding, a nearly 600% return on the NIH’s investment. During the current grant cycle (2017-
present), our 110 doctoral scholars and postdoctoral fellows have published a collective 287 manuscripts,
including 109 as primary author. The vast majority remain involved in global health research, and many have
already obtained independent grant funding. In the coming grant cycle (2022-2027), under the new LAUNCH
initiative, we build upon these strengths to further improve and expand our program. First, we will provide
enriching 12-month mentored training opportunities at affiliated research sites in 16 countries. We draw upon a
highly qualified group of US and international researchers jointly recruited from 12 domestic and 17 international
training programs funded by the NIH. Our expert mentors support experiential learning on site, while the program
provides a central training framework that monitors progress through individual development plans, core skills
checklists, and regular group check-ins. Over the course of the five-year award, we expect to support at least 60
positions via base funding; in line with the RFA, 60% will be US postdoctoral fellows. Second, we will continue
to foster research in scientific areas identified by in-country stakeholders. This includes topics described in the
RFA, as well as evolving federal and NIH priorities. Third, we will enhance our training curriculum. We have
developed a new Research Leadership Academy for Global Health, building upon our team’s experience in
global health and leadership, institutional resources, and collaborations with other US government programs.
We also provide individually guided research methodology training and scientific writing support, using proven
approaches. Fourth, we will monitor, evaluate, and learn from our activities to iteratively improve the quality of
our trainee experience. We utilize a conceptual framework that considers both process and performance to
ensure that the specific aims of the program are met. Finally, the UJMT LAUNCH initiative will be led by a team
of committed global health researchers—and a broad network of engaged collaborators, both in the US and
abroad—with the expertise and experience to carry out its ambitious aims. Through this program, we will train a
group of productive, independently funded, research leaders who are prepared to tackle the most pressing global
health issues in the years to come.

Public health relevance
NARRATIVE This program builds upon the highly successful UJMT Fogarty Global Health Fellowship, now in its tenth year. Its cornerstone is a 12-month, mentored research training opportunity at one of 30 institutions across Africa, Asia, and the Americas. We further strengthen the program with an innovative curriculum on research leadership, new approaches to enhance recruitment in global health, and research platforms aligned with regional and international scientific priorities.